2022 Optogenetic Approaches to Understanding Neural Circuits and Behavior Gordon Research Conference and Gordon Research Seminar

Project Summary
A goal of many neurobiologists is to understand how the activity of cells and circuits in the brain relate to
behavior, learning, and disease symptoms. Prior to optogenetics, it was nearly impossible to establish the
sufficiency and necessity of activity in specific cells to the generation or modification of a behavior.
Optogenetics refers to a rapidly progressing set of tools that allow researchers to use light to read out and
manipulate the activity of genetically defined brain cells. With optogenetics, it is now possible to use light to
monitor the activity of cells during behavior and then add or subtract activity from these cells to establish the
causal relationship between it and behavior. Although optogenetics is nearly universally used, the proper
design and interpretation of optogenetics-based experiments is still challenging. The goal of the 2022 Gordon
Research Conference and Gordon Research Seminar on “Optogenetic Approaches to Understanding Neural
Circuits and Behavior” meeting is to gather scientists from different disciplines and backgrounds who can
collectively present best methods for use of optogenetic tools and recent discoveries made with optogenetics
to a diverse group of scientists interested in uncovering the relationship between circuit activity and behavior.
We will bring together experts who are providing new innovations in optogenetic approaches, such as new
sensors, effectors, and microscopes, with scientists using these approaches to discover the neural
underpinnings of behavior. Our hope is through the multiple opportunities provided (i.e., oral presentations,
interactive poster sessions, community meals and free-time) both senior and junior scientists (i.e., trainees and
junior faculty) will be able to build connections and learn from each other.We request funds to help offset the
cost of travel, accommodation and registration for speakers and participants to attend this meeting.

Public health relevance
Project Narrative Optogenetics is a rapidly growing field that gives researchers tools to manipulate and read out the activity of brain cells and brain chemicals using light. The optogenetic toolbox is powerful, but the field is still figuring out how to use it rigorously. This conference will gather scientists on the cutting edge of optogenetics research, who will present to other senior and junior investigators on the latest technological developments, the strengths and limitations of the tools, and how they can be applied to addressing questions about brain and behavior.